Thalamocortical disruption as a convergence point for schizophrenia risks

Abstract
In schizophrenia (SCZ) and other psychiatric disorders, positive symptoms, such as auditory hallucinations, are
not well understood. Therefore, treatment options are limited, and most treatments are associated with
devastating side effects that result in low adherence to antipsychotic medication regimens and increased
suffering of the patient and family. Our knowledge of the mechanisms underlying positive symptoms is limited,
mostly because we lack reliable biological markers or events that can be modeled and studied. In this proposal,
we will elucidate the cellular manifestations of positive symptoms in mouse models of 2 of the strongest genetic
predictors of SCZ, 22q11.2 microdeletion syndrome (22q11DS) and 3q29 microdeletion syndrome (3q29DS).
These rare copy number variations (CNVs) increase the risk of SCZ by ~30 fold and ~40 fold, respectively.
Psychotic symptoms are clinically indistinguishable between patients with SCZ who have these microdeletions
and those who do not, and these symptoms usually appear during late adolescence/early adulthood. Our
previous work in 22q11DS mice identified disrupted synaptic transmission specifically in thalamocortical (TC)
projections between the auditory thalamus and auditory cortex (ACx), the brain areas associated with auditory
hallucinations in humans. Disruption of TC projections in 22q11DS mice occurs at 3.5 months, which corresponds
to early adulthood in humans and the age of positive symptom onset, and this disruption is rescued by
antipsychotics. The TC deficit is caused by an elevated level of dopamine receptor 2 (Drd2), a common target
of antipsychotics, and leads to reduced glutamate release from thalamic afferents. TC disruption leads to
disturbances in neuronal activity and appearances of abnormal neuronal ensembles (i.e., clusters of concurrently
firing neurons) in the ACx during silence, as measured by mesoscopic 2-photon imaging in awake 22q11DS
mice. Our preliminary data showed a similar TC disruption in the ACx of 3q29DS mice. Therefore, the overall
goal of this proposal is to identify the mechanistic overlap between SCZ risks. We will test the following
hypothesis: SCZ risks, such as 22q11DS, 3q29DS, and other SCZ-associated CNVs, independently disrupt
auditory TC projections to cause abnormal neuronal activity in the ACx. In Aim 1, we propose to characterize the
specificity and age dependency of TC disruption in 3q29DS mice and elucidate the underlying cellular and
molecular mechanisms. To generalize these findings, we will also test TC transmission in other SCZ-associated
CNVs. In Aim 2, we will characterize the abnormal neuronal activities in the ACx of 3q29DS mice to find
similarities with 22q11DS mice. We will also chemogenetically restore TC function to normalize neuronal activity
in the ACx of 3q29DS mice and 22q11DS mice. This work will identify the common mechanisms and
manifestations of positive symptoms in mice harboring CNVs that confer the strongest risks of SCZ.

Public health relevance
Relevance: Copy number variations, such as multigenic hemizygous deletions within the 22q11.2 or 3q29 genomic loci that cause 22q11.2 deletion syndrome (22q11DS) or 3q29 deletion syndrome (3q29DS), respectively, are the strongest genetic risks for schizophrenia. We found that mouse models of 22q11DS and 3q29DS have a similar, specific synaptic deficit in the auditory thalamocortical pathway, suggesting that this neural circuit is the common target of schizophrenia risks. Here we propose to elucidate the mechanisms and functional consequences of thalamocortical disruption in 3q29DS mice and to determine the degree of mechanistic overlap with other schizophrenia-associated copy number variations.